Dissemination and Implementation Science Travel Award and Conference Event (DISTAnCE)

The “Dissemination and Implementation Science Travel Award and Conference Event” (DISTAnCE) is
designed to build scientific capacity to accelerate the uptake of Dissemination and Implementation (D&I)
research across NIDCD’s mission areas (i.e., hearing, balance, taste, smell, voice, speech, and language).
D&I science aims to narrow the gap between scientific discovery and its application in health care and
educational settings to promote the adoption and integration of evidence-based practices, interventions,
and policies. The research-to-practice gap has been durable and presents a significant challenge to
furthering evidence-based practices for many disciplines. For example, despite the considerable evidence
base in communication disorders (ASHA n.d.), its clinical uptake has been disappointing (Douglas et al.,
2022b). This gap negatively impacts the health and education of millions of individuals with
communication disorders (NIDCD n.d.). Several factors have been identified that impede scientific
progress in D&I (NIDCD, 2023), but primarily, there is insufficient scientific capacity in D&I to support
noticeable growth. The need for mentoring support and cultivation of the D&I research community have
been recognized as being critical to advancing D&I research in NIDCD’s mission areas (Douglas et al.,
2022a, NIDCD, 2023). The DISTAnCE program aims to increase scientific capacity and address unmet
needs in D&I across NIDCD’s mission areas by supporting 12 awardees and 6 mentors annually to attend
(1) the “Conference on the Science of Dissemination and Implementation in Health” (CSDIH) and (2) the
new DISTAnCE Workshop, which will immediately follow the CSDIH. The DISTAnCE Workshop will
focus on topics highly relevant to NIDCD’s mission areas such as identifying and engaging stakeholders
and choosing appropriate D&I frameworks, strategies, outcomes, and funding mechanisms (e.g., Douglas
et al., 2022a, NIDCD, 2023). Critically, half of the Workshop time will be spent in mentoring periods
wherein awardees work with their mentors to refine their draft grant proposals that incorporate D&I aims
and methods. Through in-person discussions, group functions, post-workshop virtual meetings, and a
dedicated online community, DISTAnCE will strengthen the developing D&I research community. Within
the year following the DISTAnCE Workshop, awardees will broadly disseminate information learned at
CSDIH and DISTAnCE through presentations, seminars, articles, and other broad dissemination tactics.
Outcomes data regarding awardees’ success in securing funding for grant proposals that includes D&I
aims and methods will be collected at 3-years and 6-years following their participation. Over the 5-year
funding cycle, DISTAnCE aims to support the funding success of 60 promising scientists focused on D&I
research within NIDCD’s mission areas and to promote broad dissemination about the value of D&I to
nurture the pipeline of future D&I researchers and clinical implementation partners.

Public health relevance
According to the National Institute on Deafness and Other Communication Disorders (NIDCD), millions of children and adults in the United States have a communication or related disorder. The World Health Organization (WHO) reports that globally 1 in 100 children have autism, over 5% of the world’s population has disabling hearing loss, and 2.4 billion people are living with a condition that may benefit from rehabilitation including communication disorders. The “Dissemination and Implementation Science Travel Award and Conference Event” (DISTAnCE) program will provide 60 promising scientists within NIDCD’s mission areas with discipline-specific education and mentoring in dissemination and implementation science to accelerate the uptake of evidence-based interventions to improve the health and wellbeing of millions of people with communication or related disorde rs.